TRAINING PROGRAM: MECHANISMS OF VIRUS-HOST INTERACTIONS

DESCRIPTION: Plan and goals: The application requests support for a virology training program. The faculty is derived from two different entities within the New York University system, the Mount Sinai School of Medicine (MSSM) and the New York University School of Medicine (NYUSOM). The goal of the program is to assist in the training of graduate and postdoctoral students in the broad discipline of virology. The research training emphasis will be directed toward teaching students the theory and experimental approaches required for independent scientific investigations. Students will learn the molecular mechanisms involved in virus replication and host responses to viral infections. Additional research areas available for training will include novel approaches for antiviral strategies and vaccine development. By combining strengths of (outstanding) groups of virologists, they claim to be able to create a world-class virology training program which will be of great benefit to the University and research community in New York as a whole. Such a program will build upon the collaborations that already exist, including program project grants, subcontracts and joint publications between faculty members of MSSM and NYUSOM. Accordingly, the collaborative training effort has "added value" over single institution or individual based initiatives. The program faculty consist of a group of seventeen (outstanding) virologists who are using a diverse array of experimental strategies to study the molecular, cellular, biochemical and immunological interactions of viruses with their hosts. Aggressive recruitment efforts by MSSM and HYUSOM faculty have led to the attraction of high calibre trainees, including underrepresented minorities. Six pre and six postdoctoral positions are requested. The specific aims of the program are (1) to recruit and provide rigorous training to high calibre students and fellows and (2) to provide an administrative structure which will support and coordinate virology training between two entities (MSSM and HYUSOM) of the same University. The establishment of this program will aid trainees in all phases of their development, including understanding scientific method, interpretation of results, presentation of data and conclusions, research ethics and career guidance.